Comparative Omics Core

Summary: The Comparative Omics Core of the Upstate Nathan Shock Center will provide resources for
conducting aging-related proteomics, metabolomics, and genomics. Based on Mass spectrometry analyses, this
core will provide services for aging-related proteomics and metabolomics. By data integration, this Comparative
Omics Core will provide strategies to explore the aging-related genome elements and their functions in regulating
proteome and metabolome. The aims of the Comparative Omics Core are to: (1) Provide services for aging-
related proteomics. Comparative Omics Core will provide resources for conducting standard and specialized
proteomic experiments on diverse samples generated by the other Upstate NSC cores and other aging-related
projects. The core will develop methods for quantifying protein misfolding, oxidative damage, and turnover
kinetics. The core will train aging researchers in designing and interpreting proteomic experiments. (2) Provide
services for aging-related metabolomics. Comparative Omics Core will assist with the experimental design of
targeted and untargeted metabolomics studies, with a focus on comparative approaches for the identification of
aging-associated metabolites and metabolic signatures. The core will provide services for analyzing biological
samples from diverse aging models generated by other Upstate NSC cores and other aging-related projects
using high-resolution mass spectrometry. Meanwhile, Comparative Omics Core will train aging researchers to
conduct metabolomic experiments. (3) Provide computational strategies for data integration of aging-related
genome, proteome, and metabolome. Comparative Omics Core will provide computational methods to identify
aging-related genome elements (AGEs). The core will assist to identify proteome/metabolome-associated AGEs
and characterize their epigenetic features. Comparative Omics Core will develop a publicly accessible
multimodal atlas, Upstate NSC Omics Atlas, which will provide genome, proteome, and metabolome resources
across multiple species and online analysis tools to the aging research community. The central goal of the
Upstate NSC Comparative Omics Resource Core is to enable a deeper understanding of the biology of aging by
identifying and characterizing aging-related signatures in the proteome, metabolome, and genome.